CHASE: An Innovative County-Level Public Health Response to the Opioid Epidemic in New York State

Project Summary/Abstract
This supplement aims to explore the impact of the infusion of health equity principles on overdose prevention
strategies during the implementation of the Communities That Heal (CTH) intervention as part of the HEALing
Communities Study (HCS). The HCS is a multi-site, parallel arm, cluster randomized, wait-list controlled trial
evaluating the impacts of the CTH intervention, compared with usual care in wait-list communities, on overdose
deaths. The overall goal of the HCS is to reduce opioid overdose deaths by 40% in 67 HCS communities
across four states. Communities form coalitions to make shared decisions about what overdose prevention
strategies to implement and how best to implement them, particularly strategies that promote Overdose
Prevention Education and Naloxone Distribution (OEND) and Medications for Opioid Use Disorder (MOUD).
Even though minoritized communities (whether due to race, ethnicity, gender, or LGBTQIA+ status) have less
and poorer access to treatment for Opioid Use Disorder (OUD) and associated disparities in outcomes at its
outset, HCS did not explicitly aim to reduce disparities or measure the effect of centering equity on overdose
prevention. This approach changed in 2020 with an acute awareness of the racial and ethnic disparities within
the COVID epidemic and the racial awakening in response to the George Floyd killing. This supplement will
leverage its parent study existing staff and infrastructure and study staff to analyze surveys and other
qualitative data already collected. The primary data sources will include surveys of coalition members,
completed at four-time points during the study period; the Opioid-Overdose Reduction Continuum of Care
Approach Tracker (ORCCAT), completed monthly by study staff, that includes overdose prevention information
by strategy, sector, venue, population served, coalition approval date, implementation plan developed, date
started, number of partners/practices associated with strategy, and mode of delivery; and REACH data,
completed by study staff monthly once each strategy is implemented that includes information on number of
persons reached and demographics of those reached (e.g., race, ethnicity, sex, age). Data analysis will consist
of qualitative analysis looking at associations between survey answers regarding health equity topics and
incorporation of equity into strategies, and qualitative analysis examining how coalitions discussed and
prioritized equity topics. The parent study’s PRISM/RE-AIM(S) conceptual framework will guide this study
with a novel health equity lens to examine how diversifying coalitions and infusing opioid overdose prevention
strategies with health equity principles may help reach minoritized communities and how these contextual
factors and processes may interact to promote or impede health equity. Results from this study may be used to
inform policies, strategies, and practices for incorporating health equity principles when implementing overdose
prevention strategies.

Public health relevance
PROJECT NARRATIVE This supplement aims to explore the impact of the infusion of health equity principles on overdose prevention strategies during the implementation of the Communities That Heal (CTH) intervention as part of the HEALing Communities Study (HCS). We will analyze existing survey data of community coalition members, process data describing successfully implemented overdose prevention strategies, and coalition meeting minutes that provide essential context for decision-making around health equity principles. This study will be guided by the parent study’s PRISM/RE-AIM(S) conceptual framework with a novel health equity lens to examine what contextual factors and processes promoted or impeded the incorporation of health equity principles into overdose prevention strategy implementation.